Computational Chemistry and Macromolecular Modeling

During this fiscal year we devoted major effort to work aimed at applications of molecular dynamics and quantum mechanics/molecular mechanics simulations required to help support the computational chemistry and molecular modeling needs of NIEHS scientists. Some projects involved creation of solution structures of peptides and proteins using state-of-the-art molecular dynamics simulations and the others involved a careful look at the reactive dynamics at or near the active site of the biological systems of interest. Several docking studies and energy characterization studies are highlights of our efforts. Most computational chemistry and molecular modeling tools that have been utilized in the present research efforts are either developed by us or modified by us. Almost all tools used in the analysis of molecular dynamics trajectories required to obtain predicted solution structures and in the energy decomposition schemes of QMMM calculations are also written by us. The current list of projects includes (but not limited to) mutational studies of Tristetraproline (a protein involved in RNA degradation) that affects RNA binding; Top2 reaction dynamics, dynamics of HIV reverse transcriptase and its constituents (P51 and P66) along with some critical mutations that effect the function, construction of a solution structures for human constitutively active receptor (hCAR) and its cofactors and running long molecular dynamics of a related protein PPARgamma, modeling of DNA polymerase activity with the inclusion of some ribonucleotides in the DNA sequence at both classical and QMMM level, ribonucleotide insertion in DNA during polymerization catalysis using QMMM methods, interaction predictions of various CNOT proteins, binding of various small molecules such as BPA and its derivatives on estrogen and androgen receptors, structure and binding of glucocoticoid receptor, quantum mechanical characterization of some flame retardant molecules, solution structures from de novo modeling of SMCHD1, role of various metal ions in nucleotide insertion, GATA3 mutant modeling, modeling dGTP Triphosphohydrolase, Green Fluorescence Protein (GFP) modelin, lipid interactions with allergen proteins such as Bla g1, damaged DNA structure characterizations using molecular dynamics simulations. In addition, as a measure for efficient spending and also as a precautionary measure to carry out our functions under constraints of budgetary restrictions, we have been continuing to explore the idea of setting up computer servers based on low cost, off-the-shelf components and GPUs to run MD simulations that require heavy utilization of multiple processors to tackle systems with millions of atoms and to complete QMMM calculations that demand access to a large sum of memory at a given instance.